RISK FACTORS FOR ALCOHOLISM IN NATIVE AMERICANS

Although tribes differ with regard to the use of alcohol Native Americans, as a group, have the highest alcohol-related death rates of all ethnic groups in the United States. However, how and why alcoholism is more prevalent in some Native American communities remains unclear The overall objective of this research plan is to enhance understanding of the biological risk and protective factors related to alcohol dependence and alcohol-related problems in reservation dwelling Indians indigenous to San Diego county (collectively called Mission Indians). The studies proposed in this application include cross-sectional studies in Mission Indian adults and adolescents, as well as longitudinal studies in Native American children and adolescents. This design allows for the investigation of specific genetic and environmental risk factors existing both prior to alcohol exposure and during the development of drinking patterns. The four aims of the study are: (1) To find identifiable neurobiological factors in Native American youth who progress from alcohol use to abuse, and to dependence; (2) To document whether exposure to high levels of alcohol in adolescence lead to specific and detrimental medical and psychological outcomes; (3) To identify circumstances and mechanisms of behavioral change that lead to either continued alcohol use and disability or remission from alcoholism in this population; and (4) To determine why Native American Mission Indian adults are at such high risk for alcoholism through the identification of specific genetic and environmental factors. These studies have the potential to verify whether Native Americans have any specific biological/genetic, psychosocial or behavioral factors that may help to explain the high risk for alcoholism within the tribes evaluated. The identification of such variables may potentially be useful in the development of specific prevention and treatment programs for this population as well as other Native American tribes.

Public health relevance
RELEVANCE (See instructions): This study has the potential to provide critical information for understanding how select genetic and environmental factors might interact in the development of alcohol use disorders among Native American men and women living in San Diego County. Ultimately, a better understanding ofthe factors associated with alcohol associated behaviors in Native Americans will contribute important information for understanding the causes of alcohol abuse and dependence and might ultimately aid in the development of efficacious and culturally sensitive prevention and intervention programs.